Remodeling the microtubule cytoskeleton during epithelial cell division and differentiation

Project Summary/Abstract
Dividing and differentiating cells require different arrangements of microtubules to function, and the goal of
this proposal is to understand how differentiating cells reorganize their microtubules in order to divide. Mitotic
cells use centrosomes as their microtubule organizing centers (MTOCs) to form radial microtubule arrays that
help split the cell into two daughters. Differentiating cells often designate a non-centrosomal sites as their MTOC.
In polarized epithelial cells, the apical membrane is the MTOC, and it forms parallel microtubules arrays that are
important for cell polarity and intracellular transport. However, epithelial cells often divide in development, tissue
maintenance, and cancer, presenting an obstacle: they must temporarily lose their parallel microtubules and
reestablish radial microtubule arrays. Little is known about how epithelial cells accomplish this reorganization,
which is critical for successful cell division.
This proposal will use two complementary models, the developing C. elegans intestine and primary human
intestinal “organoid” cells, to uncover the mechanisms that epithelial cells use to remodel their microtubule
cytoskeleton for division, and the consequence of disrupting this remodeling in development and disease. The
C. elegans embryonic intestine is a simple in vivo epithelial tube that is easy to visualize and manipulate, with a
fixed number of cells that undergo microtubule remodeling to divide. In addition, many of the proteins used in C.
elegans for cell division and microtubule organization are conserved, making it an ideal context for discovering
new genes and mechanisms that regulate microtubule organization in other systems. By combining the Feldman
lab’s recently developed techniques with classic ones, the proposed experiments will identify the factors that
physically hold and release microtubules at the non-centrosomal MTOC, and the molecular signals that cause
this localization to change concordant with cell division. These newly discovered genes and pathways will be
tested for a conserved role in primary human intestinal cells, and for cancer-related defects resulting from
disrupted microtubule organization.
This proposal addresses the fundamental biological question of how polarized cells reorganize for cell
division. The proposed experiments will cover the entire award period, and technical training during the mentored
phase will facilitate experiments in the independent phase. A team of expert mentors and collaborators will train
Dr. Sallee in new methods that are critical to the success of this research. In addition, Dr. Sallee will participate
in local meetings and scientific conferences, attend career planning courses, and meet regularly with her mentors
and advisory committee to discuss her scientific progress and to prepare for job applications and interviews.
Both of Dr. Sallee’s mentors are fully committed to her success in establishing her research plan that she will
take with her to start an independent academic research lab.

Public health relevance
Project Narrative Epithelial cells line the body and organs of animals, and they are the source of carcinomas, the most common human cancer. They organize rod-like structures called microtubules into parallel arrangements, which they must reorganize in order to divide. The goal of this proposal is to understand the physical protein links and the molecular signals that allow epithelial cells to toggle between different microtubule arrangements during cell division.